Heterogeneity in bacterial quorum sensing during infection

PROJECT SUMMARY
All animals depend on bacterial symbionts for specific traits that promote their fitness. The mechanisms by
which hosts acquire and select for those symbionts remains unclear but important to develop new strategies
and therapeutics based on bacteria to improve host health. The symbiosis established between the Hawaiian
bobtail squid and the bioluminescent bacterium Vibrio fischeri is a powerful model to examine the molecular
mechanisms that promote symbiont assembly and colonization in a host. This supplement seeks support to
collect and maintain a cohort of squid to complete studies associated with the main project that were adversely
affected by a critical life event involving the project PI. The proposed activities will 1) determine the extent of
expression of a small regulatory RNA within host-associated bacteria, and 2) determine how the import of a
host-derived sulfur source impacts V. fischeri physiology in vivo. Squid colonization assays with defined
bacterial mutants will address each research question, thereby completing two studies. Together, these
experiments will provide knowledge of how V. fischeri cells are acquired and acclimate to the squid host
environment, which is insight that will increase understanding of how bacterial symbionts successfully establish
symbiosis with a host.

Public health relevance
PROJECT NARRATIVE Interactions with bacterial symbionts are important for human health and physiology, but the mechanisms that promote their assembly within a host are poorly understood. The proposed project involves the examination of the symbiosis naturally established between a squid and the bacterium Vibrio fischeri as an experimentally tractable model to investigate gene regulatory networks that facilitate symbiont assembly. Because such bacterial symbionts have the potential to increase host fitness, these studies will improve human health by increasing understanding of how signaling systems facilitate assembly of beneficial microbes.